CD8+ T CELL REPROGRAMMING TO BOOST ANTIVIRAL POTENTIAL AGAINST CHRONIC INFECTION

PROJECT SUMMARY/ABSTRACT
There is substantial evidence that stem-like CD8+ T cells have a central role in the natural
control of chronic viral infection. For example, virus-specific CD8+ T cells from HIV-1 natural
controllers have enhanced antiviral potential, related to the development of stemness
properties, including high survival, polyfunctionality, and proliferative potential. Similar
observations have been made for other chronic viral infections in humans, such as Hepatitis
B virus (HBV). The development of stem-like memory CD8+ T cells thus appears crucial to
achieving natural control of chronic viral infections. Considering the lack of cure for
prevalent chronic viral infections such as HIV-1 and HBV, we propose that future therapies
aiming at remission of these diseases require reprogramming CD8+ T cells to exhibit stemness
properties, via cellular adoptive transfer or direct administration of immunomodulatory
drugs. In previous studies, we optimized a system to reprogram HIV-specific CD8+ T cells
from non-controller individuals to improve their functional qualities, using a GSK3 inhibitor.
Given these findings, we hypothesize that HBV-specific CD8+ T cells from individuals with
chronic infection will benefit from this reprogramming method and enhance their functional
qualities. To further elucidate the effectiveness of such CD8+ T cell reprogramming to boost
their antiviral functions in other chronic viral infections, here we aim to: i) Evaluate the
impact of our established method of reprogramming on the antiviral potential of HBV-
specific CD8+ T cells from individuals with chronic infection, in terms of cytokine production,
proliferation, survival, and the response to immune checkpoint blockade; ii) To compare the
functional profile of reprogrammed HBV-specific CD8+ T cells with cells derived from
individuals who reached functional cure of HBV infection. The results of this proposal will
help to better understand the therapeutic potential of CD8+ T cell reprogramming by
targeting transcriptional and metabolic pathways, in the search for the remission of prevalent
chronic viral infections.

Public health relevance
PROJECT NARRATIVE These studies are relevant for public health since they focus on the development of novel immune therapies aiming at the cure of a prevalent chronic viral infection (HBV).